PRECLINICAL TOXICOLOGY &PHARMACOLOGY OF DRUGS DEVELOPED

The objective of this contract is to acquire pharmacologic and toxicologic data on new drugs for the treatment of Cancer and the Acquired Immunodeficiency Syndrome (AIDS) and AIDS-related illnesses. The data will be included in an Investigational New Drug (IND) application to the FDA which is required prior to the initiation of human clinical trials. Level A contract is 46,875 hours over 5 years. Level B contract is 93,750 hours over 5 years. This contract will be awarded at Level B because the laboratory has the capability, expertise and experience to do the amount of work required.